Mechanisms of glioma initiation by IDH oncogenes

PROJECT SUMMARY
Lower grade gliomas, as well as the high grade gliomas that arise from them, are now diagnostically defined by
the presence of mutations in genes encoding isocitrate dehydrogenase (IDH) enzymes. Mutant IDH enzymes
synthesize the oncometabolite (R)-2HG. (R)-2HG accumulates to millimolar levels in IDH-mutant glioma cells
and inhibits 2-oxoglutarate-dependent enzymes, including the TET and KDM dioxygenases that catalyze DNA
and histone demethylation, respectively. Thus, (R)-2HG cells causes chromatin hypermethylation and
epigenetic reprogramming. IDH mutations occur first in the series of genetic alterations that cause lower grade
gliomas, suggesting that they play an important role in tumor initiation. However, our understanding of the
precise targets of (R)-2HG-induced epigenetic reprogramming that drive neural cell transformation is limited.
This limitation is tied to the difficulty in using primary samples from established tumors to retrospectively study
tumor initiation. To address this issue, we created a genetic mouse model of astrocytoma and performed time-
resolved single-cell multi-omics analyses of the alterations caused by mutant IDH during premalignancy and
tumor initiation. We found that mutant IDH repressed neuroblast and interneuron cell lineages and expanded
oligodendrocyte precursor cells prior to tumor formation. Moreover, we found that oligodendrocyte precursor
cells, but not neuroblasts and interneurons, were permissive to transformation. These data suggest that altered
lineage specification of neural progenitor cells may be a key mechanism of glioma promotion by IDH
oncogenes. To identify molecular changes that cause this effect, we performed a cross-species transcriptomic
analysis of IDH-mutant and IDH-wildtype tissues. We identified mutant IDH-induced silencing of a lineage-
specific transcription factor that is required for interneuron differentiation. This silencing event was associated
with DNA hypermethylation of an associated CpG island. Based on these findings, we hypothesize that
epigenetic reprogramming by (R)-2HG drives glioma initiation by inhibiting neuronal specification of neural
progenitor cells, thereby expanding the pool of oligodendrocyte precursor cells that are susceptible to
transformation by glioma-associated mutations. We will test this hypothesis through three specific aims. In
Specific Aim #1, we will examine the relationship between DNA hypermethylation and silencing of the identified
interneuron-specifying transcription factor in human and mouse samples. In Specific Aim #2, we will test
whether ectopic expression of this transcription factor reverses mutant IDH-induced lineage reprogramming of
neural progenitor cells in vivo. In Specific Aim #3, we will ask if altered neural progenitor cell lineage priming
drives gliomagenesis downstream of IDH mutations and whether a gene involved in this process may serve as
a biomarker of response to mutant IDH inhibitors, which have shown anti-glioma activity in the clinic. If
successful, our work may reveal the molecular and cellular dynamics that drive IDH-mutant glioma initiation
and nominate new approaches to monitor and predict response to IDH inhibitor therapies.

Public health relevance
PROJECT NARRATIVE Mutations in genes encoding isocitrate dehydrogenase (IDH) enzymes occur first in the cascade of genetic changes that lead to the formation of adult-type lower grade brain tumors (gliomas) but the mechanisms of tumor initiation by IDH oncogenes are not well understood. To address this issue, we created a genetic mouse model of this disease which revealed that IDH mutations alter the function and fate of neural stem and progenitor cells prior to tumor development. We propose to test whether these alterations play a causal role in brain tumor initiation, identify the underlying cause of these alterations at the molecular level, and determine whether our findings may inform new biomarkers of response to mutant IDH inhibitors, which are being developed clinically for brain tumor therapy.